Prion and non-prion induction mechanisms of alpha-synuclein pathology

The presence of a-synuclein brain aggregates are a hallmark of a
spectrum of neurodegenerative disorders, including Parkinson disease, Lewy body dementia
and multiple system atrophy, and are associated with disease severity. Several studies suggest
that this a-synuclein pathology may spread during disease progression by a self-templating
mechanism and that nervous tissue containing aggregated a-synuclein could be a risk for
disease transmission similar to prion disease. However, we recently demonstared that a non--
synuclein factor enriched in central nervous tissue-derived white matter is sufficient to induce
the progressive formation of a-synuclein inclusion pathology that can mimic prion-like
transmission of a-synuclein pathology. These observations suggest the presence of a yet
unidentified factor that can trigger a-synucleinopathy, similar to protein X, a putative auxiliary
factor in prionopathies. Furthermore, this factor may have a pathogenic role in human disease.
To resolve critical issues at the core of whether synucleinopathies should be re-classified as
prion disorders and to elucidate mechanisms involved in disease progression we propose the
following aims: 1) characterize the biochemical properties of the non-a-synuclein component
that can trigger the progressive formation of a-synuclein, 2) determine whether a-synuclein
aggregates can truely exhibit properties expected of classical prions, and 3) determine the
relative prion-like transmission properties of central nervous tissue from patients with multiple
system atrophy and Lewy body dementia, two phenotypically distinctive a-synucleinopathies.
These highly integrated aims will provide important mechanistic and biologically relevant insights
into the mechanisms and risk of pathology transmission from tissues containing a-synucleinopathies.

Public health relevance
Parkinson's disease and Lewy body dementia are neurodegenerative disorders associated with the progressive accumulation of a-synuclein inclusions within the nervous system. The proposed studies will investigate the biological agents present in the nervous system, including the intrinsic transmissible nature of a-synuclein aggregates, which can trigger the progressive formation of a-synuclein pathology. Our findings will have important implications in assessing transmission mechanisms and risks associated with diverse invasive medical procedures.